Homeostatic control of bacterial growth and cell division

PROJECT SUMMARY The Project Summary is contained within the Research Strategy per NOT-GM-21-030 guidelines.

Public health relevance
Project Narrative Our research seeks to identify and characterize the regulatory circuits coordinating bacterial growth and reproduction with fluctuating environmental conditions to ensure the efficient use of valuable resources. Defects in these circuits render bacteria highly sensitive to antimicrobial compounds. Illuminating the molecular organization of these circuits is essential to understand their contribution to the rise of antibiotic resistant pathogens and to assist in the design and development of antimicrobials that can defeat them.